Proteostasis maintenance of neuroreceptors by an ER-phagy receptor

Project Description
Selective autophagy plays an important role in maintaining cellular homeostasis in various
organelles. Since proteins in the secretory pathway and membrane proteins must fold into their native
structures in the endoplasmic reticulum (ER) before their anterograde trafficking, selective autophagy of
the ER, or ER-phagy (reticulophagy), has been recently recognized as an important protein quality
control pathway of aggregation-prone proteins in the ER. A key development of ER-phagy is the
identification of six specific transmembrane ER-phagy receptors, including CCPG1, the focus of this
research. However, there is a significant gap about the role of many of these ER-phagy receptors in
physiological and pathophysiological conditions, especially in the central nervous system (CNS). The
CNS must maintain a delicate balance between inhibition and excitation. The inhibitory signal is mainly
dictated by gamma-aminobutyric acid type A (GABAA) receptors. Proteostasis maintenance of GABAA
receptors is critical since their proteostasis defects lead to neurological diseases, such as epilepsy and
developmental delay, resulting from variations in genes encoding these neuroreceptors. We and other
groups have demonstrated that one major disease-causing mechanism is due to the protein misfolding
of these variants in the ER and thus their reduced trafficking to the cell surface for function. Preliminary
data demonstrated that GABAA receptor variants that aggregate in the ER are targeted to the lysosome
for degradation; furthermore, among the known six membrane ER-phagy receptors, only CCPG1
interacts with the variants to promote clearance. However, the role of CCPG1 in the CNS is unknown
yet. Therefore, based on preliminary data, we hypothesized that CCPG1 directs aggregation-prone
GABAA receptor variants in the ER to the ER-phagy pathway, and loss of function of CCPG1 leads to
protein aggregation and proteostasis deficiency in neurons. We proposed to test the hypothesis with
the following specific aims by combining approaches in cell biology and electrophysiology. Here, in
Specific Aim 1, we will elucidate CCPG1-mediated ER-phagy pathway for pathogenic neuroreceptor
variants. In Specific Aim 2, we will determine the effect of CCPG1 on proteostasis maintenance of
neurons.

Public health relevance
Project Narrative ER-phagy has been recently recognized as an important protein quality control pathway of aggregation-prone proteins in the endoplasmic reticulum. CCPG1, an ER-phagy receptor, is indicated to be involved in neurodevelopmental diseases. Here, we propose to elucidate the molecular mechanism of CCPG1 in maintaining neuronal proteostasis, which can be further developed for the treatment of CCPG1-associated diseases.